Expansion of Pennsylvania's State Food and Feed Laboratory Services in Response to the 2011 Food Safety Modernization Act, Laboratory Accreditation Rule, and the FDA Integrated Food Safety System

Abstract
As a large state with a population of nearly 13 million, and an economic value of 6.1 billion in
Pennsylvania agriculture, it is of primary importance for Pennsylvania to possess a laboratory dedicated
to the analysis of food and feed products in order to provide defensible knowledge concerning the
safety and integrity of the products produced by the commonwealth. The integrity of this knowledge is
critical to inform decision makers in the production of public policy and protection of public health.
In 2015 the Laboratory Division of the Pennsylvania Department of Agriculture Bureau of Food Safety
and Laboratory Services (“Laboratory”) began its participation in the Food and Drug Administration’s
Animal Feed Regulatory Program Standard Cooperative Agreement Program with the primary goal of
achieving accreditation to the ISO/IEC 17025 standard, that defines the competence of testing and
calibration laboratories. In 2020, the Laboratory is set to achieve this goal and is looking toward
expanding the scope of its accreditation to better support its Food and Feed regulatory programs, and,
in turn, support the FDA Integrated Food Safety System created under the 2011 Food Safety
Modernization Act. To do this, the Laboratory is focused on four goals pivotal to the development of its
services: 1) To strengthen its utilization of quality management and continuous improvement, 2) to
expand its scope of accreditation and testing capabilities, 3) to establish and expand manufactured food
and feed product testing for regulatory purposes, and 4) to continue to develop lasting laboratory
partnerships.

Public health relevance
Project Narrative Food and feed safety laboratories serve to create public goods through the creation of knowledge using analytical science that informs the creation of sound policy, provides consumer confidence against adverse economic impacts in a global marketplace, and protects the health of the general public from food and feed adulteration or pathogenic outbreaks. The accreditation of food and feed safety laboratories, through ISO/IEC 17025, is considered a gold standard in demonstrating the competence to perform defensible laboratory science in support of these public goods. The Laboratory Accreditation Rule of the 2011 Food Safety Modernization Act, implemented by the Food and Drug Administration, makes the activity of achieving and maintaining accreditation pivotal for food and feed safety laboratories to actively participate in a fully integrated food safety system.